Early Access to Kidney Transplantation among Patients with Lupus Nephritis

PROJECT SUMMARY
Systemic lupus erythematosus (SLE) is a chronic, multisystem autoimmune disease that can result in a serious
renal manifestation known as lupus nephritis (LN) and eventually, LN-associated end-stage kidney disease
(LN-ESKD). The development of LN-ESKD among patients with SLE is of particular concern due to its high risk
of premature death and its disproportionate impact on younger patients and patients of minority race and lower
socioeconomic status. There are only two treatment options for patients with LN-ESKD, and research suggests
that kidney transplantation provides a greater survival benefit compared to long-term dialysis. Despite this, the
majority of LN-ESKD patients are initiated on dialysis and it is largely unknown how soon after progression to
ESKD that the kidney transplant process is initiated and what socioeconomic and health system barriers may
hinder this treatment transition in this population. The kidney transplant process is complex for patients and
requires coordinated communication across multiple providers and health systems, including primary care
providers, nephrologists, dialysis facilities, and transplant centers. The overarching goal of this research
proposal is to characterize early access to kidney transplantation among adult (≥18 years) patients with LN-
ESKD in the U.S. by evaluating the impact of socioeconomic and health systems processes on the first step in
the kidney transplant process, referral for an evaluation at a transplant center. This research will leverage
national surveillance data of ESKD patients from the United States Renal Data System (USRDS) linked with
novel patient referral information from the Early Transplant Access Registry that is not collected in national or
regional surveillance systems to examine this critical and necessary first step to accessing a transplant. Aim 1
will estimate the timing of 1) kidney transplant referral from ESKD start comparing LN-ESKD patients to
patients with ESKD unrelated to LN, using Cox proportional hazards models. Aim 2 will evaluate the
association between neighborhood poverty and referral for kidney transplant in patients with LN-ESKD and the
potential mediating effect of visiting a kidney specialist prior to ESKD start. Aim 3 will use cross-classified
logistic multilevel models to determine the influence of health system factors (including dialysis facility and
transplant center characteristics) on referral for kidney transplant in patients with ESKD. The results from this
proposed research project will provide insight into the epidemiology of referral for kidney transplant in LN-
ESKD patients. Furthermore, it will inform clinical practice among clinicians treating patients with LN-ESKD by
emphasizing the importance of timely referral for kidney transplant to reduce patients’ time spent on dialysis
and death from other causes while on the waitlist. These results will also inform development of targeted
interventions to improve access to a nephrologist prior to progressing into ESKD and to enhance patient care
coordination across healthcare systems between dialysis facilities and transplant centers.

Public health relevance
PROJECT NARRATIVE Kidney transplantation is one of two treatment options for patients with lupus nephritis-associated end-stage kidney disease (LN-ESKD), although there is little information regarding access to early steps in the kidney transplant process for this patient population. The proposed research project will use a multilevel approach to evaluate access to referral for an evaluation at a kidney transplant center (the first step in the kidney transplant process) in patients with LN-ESKD by examining socioeconomic and health system factors that may be impacting referral access. The results of this project could be used to inform interventions that focus on timely referral for kidney transplant and ultimately improve long-term outcomes among LN-ESKD patients.